TROGLITAZONE, METFORMIN, &SULFONYLUREA IN INSULIN STIMULATED GLUCOSE

The objective of this study is to assess the potential mechanism by which Troglitazone improves skeletal muscle insulin sensitivity in patients with Non-Insulin Dependent Diabetes Mellitus (NIDDM) and compare these to the effects of Metformin and sulfony-lurea treatments. The hypothesis to be tested is that troglitazone has a greater effect to improve skeletal muscle insulin sensitivity than does metformin or sulfonylurea therapy. This will be tested by comparing across three treatment groups the impact of treatment for PET parameters, skeletal muscle oxidative enzymes...